Identification of opioid-induced innate immune dysregulation among people living with HIV

Project Summary
Highly active antiretroviral therapy (ART) has dramatically improved survival and reduced progression to AIDS
for people-living-with-HIV (PWH). However, PWH remain at significantly increased risk for diseases associated
with chronic systemic inflammation, such as coronary artery disease, stroke, cognitive disorders, and some
malignancies. Substance-use-disorders (SUD) are associated with HIV-disease progression, regardless of ART
use. Understanding if and how opioids impact immunity among PWH is important due to the increased risk of
opioid-use-disorder (OUD) among PWH, and the vulnerability of PWH to co-morbidities driven by immune
dysregulation. This proposal aims to determine if chronic opioid exposure (COE) among PWH who are
experiencing OUD is a driver of dysregulated innate immunity. Our published work and preliminary data
demonstrate that monocytes are vulnerable to opioid-associated disruption of both pro- and anti-inflammatory
functions among PWH, regardless of HIV viral load. In this dissertation proposal, I will address my hypothesis
that COE among PWH results in increased reliance on glycolysis during a resting state, disruption of mTORC1
signaling, and impaired metabolic plasticity in response to stimulation that compromises both pro- and anti-
inflammatory monocyte functions. Findings from this proposal will open the door for therapeutics that ameliorate
opioid-induced monocyte dysregulation and advance our understanding of the off-target effects of long term
opioid-exposure.

Public health relevance
Project Narrative As the rate of opioid use disorders continues to rise in the United States, it has become important to understand how chronic opioid exposure alters the immune system, particularly among people-living-with-HIV who already experience compromised immunity and diseases driven by chronic inflammation. This research will determine if chronic opioid exposure disrupts monocyte immunometabolism and function among people-living-with-HIV who also suffer from opioid-use-disorder. Findings from this proposal will reveal the off-target effects of long-term opioid-exposure on innate immunity and open the door for therapeutics that ameliorate opioid-induced monocyte dysregulation.